2022 Systems Aging Gordon Research Conference

Project Abstract
This application requests funds to support the inaugural 2022 Systems Aging Gordon Research Conference (GRC),
to be held at Grand Summit Hotel at Sunday River (Newry, Maine, USA) on May 29- June 03, 2022. The last several
years have seen an explosive growth of research on quantitative, omics and whole-organismal approaches to aging,
longevity, and age-related diseases. This includes the development of reliable biomarkers of aging that facilitate human
clinical trials of longevity and new insights in fundamental mechanisms of aging that act on a systemic level. These
developments are distinct but complementary to the advances in mechanistic studies, which forms the basis for another
GRC on aging (Biology of Aging). Emerging from systemic, quantitative, biomarker approaches is a new understanding
of aging, which can be tracked, monitored, manipulated and in some cases reversed. Systems Aging GRC is expected
to become the premier forum for discussions at the forefront of this new field that transcends the historic separation into
basic biology of aging and the treatment of age-related diseases. The theme of the 2022 conference will be Systemic
Processes, Omics Approaches and Biomarkers in Aging. To link, cross-pollinate and integrate investigators from
diverse areas, sessions are organized around the following themes: Delaying and Reversing Aging, Whole Organism
Approaches and Rejuvenation, Genomics of Aging, Epigenetic Biomarkers of Aging, Clinical and Molecular Biomarkers
of Aging, Artificial Intelligence and Machine Learning, Aging as a Systemic Process, Comparative Genomics of Aging,
and Fundamental Bases of Aging. Our organizational principles are to develop: 1) a comprehensive program that
features key advances in the field; 2) an atmosphere that facilitates discussion, critical analysis and exchange of ideas
between scientists from diverse fields working on systemic approaches to aging; 3) a venue that promotes interactions
among established investigators, junior colleagues, postdocs and students; 4) a strategy to support women,
underrepresented minorities and junior investigators as well as foster career advancement of investigators from diverse
backgrounds; and 5) a conference that will become a home base to people working in this emerging field.

Public health relevance
Project Narrative The 2022 Systems Aging Gordon Research Conference will cover recent exciting advances in systemic and quantitative approaches to aging research, including biomarkers of aging, epigenetic clocks, omics, cross-species analyses, rejuvenation and clinical applications. The inaugural meeting will bring together a multidisciplinary group of established and junior scientists to discuss the latest advances in these areas in a setting that supports diversity, career development and collaboration.